Health Communications for Adults Smoking Nondaily

PROJECT SUMMARY
Adults smoking nondaily (ASN) make up approximately one-third of adults who currently use cigarettes in the
U.S. and experience substantial risk of cancer, respiratory, and cardiovascular mortality. Yet, ASN often do not
perceive themselves as vulnerable to health consequences of smoking and are less likely than those smoking
daily to attend to or be persuaded by smoking health risk campaigns targeted to the general population adults
who smoke. It is critically important to develop smoking health risk messages targeted to ASN that are
perceived as personally relevant and meaningfully influence key outcomes associated with smoking cessation.
As the first step in a programmatic line of research designed to improve health communications for and smoking
cessation outcomes among ASN, we propose to develop and carefully evaluate theoretically-based smoking
health communications targeted to ASN intended to increase knowledge, worry, risk perceptions, motivation,
and intentions to quit. The Communication-Persuasion Matrix (CPM) offers an overarching conceptual
framework for developing and evaluating targeted messages. We will pursue two aims. In Aim 1a, guided by the
CPM and empirical evidence that affect and social cues are especially strong predictors of smoking behavior
among ASN, we will develop smoking cessation messages with content that varies on affective valence
(positive vs. negative) and smoking consequences (social vs. health). Factors specifically relevant to ASN will
be targeted, including the perception that they are not “smokers” and social cues for smoking. In Aim 1b,
Learner verification and revision procedures with ASN (N=20) will be used to evaluate the initial messages for
comprehension, attractiveness, acceptability, and personal relevance. Messages will be modified in an iterative
process according to participant feedback throughout learner verification and revision. In Aim 2, in a 2x2
factorial design, the optimized messages from Aim 1 will be presented to ASN via an online panel (N=320) to
test the effects of message affective valence (positive vs. negative) and consequences (social vs. health).
Participants will be randomized to view one of four categories of messages: Positive/Health, Positive/Social,
Negative/ Health, Negative/Social. Key outcomes will be assessed pre- and post-message exposure. We
hypothesize that positive (vs. negative) and social (vs. health) messages will produce greater increases in
knowledge, worry, risk perceptions, motivation, and intentions to quit smoking among ASN. Identifying
underlying components of effective messaging for this vulnerable group is especially impactful as findings can
inform the development of future targeted messaging or smoking cessation campaigns. In the future, we plan to
conduct a fully powered RCT to evaluate the efficacy of the targeted messages at enhancing motivation to quit
and examining quit attempts and tobacco treatment enrollment among ASN, a substantial, at risk, and
underserved population of U.S. adults who smoke.

Public health relevance
PROJECT NARRATIVE Adults smoking nondaily have substantial risk of experiencing tobacco-related cancer, respiratory, and cardiovascular morbidity and mortality, yet are less likely to pay attention to general messages encouraging them to quit smoking. In this study, we will 1) develop messages specifically designed to be relevant to adults smoking nondaily, 2) refine the messages with input from adults smoking nondaily, and 3) test which messages elements are most important and whether the messages increase risk perceptions and intentions to quit smoking. The ultimate goal of the study is to optimize messages for adults smoking nondaily to be used in future interventions to increase smoking cessation treatment enrollment and quitting for this underserved group.